HIV IN INFANTS--EARLY IMMUNITY AND VIRAL SUSCEPTIBILITY

Addresses 2 issues currently important in Pediatric HIV infection: 1) development of an improved method to diagnose infection of newborns, and 2) determination of why only some offspring from infected mothers are HIV-infected. Tests hypotheses that HIV-infected newborns mount IgM antibody responses recognizing "native" conformational gp160 epitopes similar to those observed here in early infected adults, and that differential mother to offspring transmission of HIV involves the infant's genetic susceptibility to the mother's isolate virus.